Neuroscience Resident Research Program

ABSTRACT
This is an R25 program renewal proposal describing the Research Training Program for Neurology and
Neurosurgery Residents at Massachusetts General Hospital (MGH) and Brigham and Women’s Hospital
(BWH) of Harvard Medical School (HMS). The program combines a broad variety of collaborative research
opportunities available at these campuses together with a dedicated group of neuroscience mentors. Further,
our mentors are aligned in a two-tiered system that includes a ‘research’ mentor who is directly responsible for
the scientific activities of the candidate and a secondary ‘gateway’ mentor who is additionally responsible for
oversight and career development of the R25 candidate. Research mentors are selected from a vast field of
research scientists at our two institutions together with those of the Boston area. The gateway mentors are
selected on the basis of research activity, experience guiding clinicians in the early stages of successful
research careers, and commitment to this program in order to develop our residents into effective physician-
scientists. In addition, a steering committee oversees all aspects of the resident research training experience
and provide guidance to trainees on mentor selection and grant submissions. This program has already proven
to be tremendously successful in its first 14 years of funding. The R25 program has sponsored 76 trainees
(including those still in the program), many of whom have produced high-impact first author publications as well
as earned foundation and K12, K23 and K08 funding soon after completing this program. Many have also gone
on to become academic faculty at institutions across the country and have developed highly productive
research careers with consistent NIH funding support. Altogether, the programmatic structure provided in this
renewal builds on the past success of our program and aims to ensure that our Neurology and Neurosurgical
residents obtain the highest level of training possible. It also aims to ensure that we continue to foster the
development of outstanding physician-scientists through our combined Neurology and Neurosurgery programs.

Public health relevance
NARRATIVE Neurologic illness continues to make up a large burden of the morbidity and mortality of the population in the United States. This need can only be met by continuing to sustain the physician-scientist career pathway to bring innovative translational solutions to neurological health problems. This application looks to renew a highly successful program that leverages the vast resources of the Harvard hospital system and links neurology and neurosurgery trainees with established scientists who have a strong track record of mentorship to foster the careers of the next generation of physician-scientists focused on diseases of the nervous system.